ARTERIAL DISEASE MULTIPLE INTERVENTION TRIAL (ADMIT)

It is known that individuals with peripheral arterial disease are at increased risk for cardiovascular morbidity and mortality. In order to facilitate design of a trial to evaluate the effects of intervention on risk factors on morbidity and mortality in such patients a feasibility study (ADMIT) has been designed to evaluate the ability to recruit, treat and retain volunteers in anticipation of a large scale multi-center study focusing on risk factor reduction.